Olfactory Glomeruli: Cellular and Network Mechanisms

DESCRIPTION (provided by applicant): Glomerular circuits are important. They transform sensory input into output signals that impact all downstream olfactory networks. Inhibition is key to these transforms. Intraglomerular inhibition presynaptically regulates sensory synapses and provides feedback and feed forward inhibition that shapes the strength and temporal structure of M/TC responses to sensory signals. Less is known about interglomerular inhibition. Exciting new data show that short axon cells, which form the interglomerular circuit, co-release GABA and DA. These co-transmitters trigger a temporally biphasic inhibitory-excitatory response in external tufted cells, neurons critical to glomerular circuit function. They also generate strong, temporally asymmetric, direct inhibition of M/TCs such that early-activated glomeruli inhibit their later activated neighbors, leading to The early bird gets the worm hypothesis. These discoveries were made using optogenetics combined with recordings from identified gene-targeted cell-type specific neurons. Little is known about DA release or it's metabolism in the bulb. Fast Scan Cyclic Voltammetry will be used to define the kinetics of DA release in vitro and in vivo. New data suggest that FDA-approved COMT inhibitors may enhance bulb DA function; this could benefit Parkinson's patients. We will test this hypothesis. Inhibitory-inhibitory interactions among inter- and intraglomerular neurons have not been explored. Pilot data using optogenetics combined with identified cell recordings indicate robust interactions. We will define inhibitory-inhibitory interactions, their synaptic dynamics and how they shape intra- and interglomerular signaling.

Public health relevance
PUBLIC HEALTH RELEVANCE: Glomeruli circuits are important. They transform unprocessed sensory signals into M/TC outputs that impact all downstream olfactory networks. Inhibition plays a key role in these transforms. Intraglomerular regulates the strength and temporal structure of glomerular output responses to sensory input but less is known about interglomerular inhibition. Exciting new data indicate that the interglomerular synapses co- release GABA and DA, which trigger a temporally bi-phasic inhibition-excitation response in in neighboring glomeruli to gate sensory coding during sniffing. DA and olfaction are impaired in Parkinson's disease. We will determine if FDA-approved COMT inhibitors ameliorate olfactory deficits in Parkinson's. New data using optogenetics indicate that interactions among glomerular inhibitory neurons are robust. We will investigate how these inhibitory-inhibitory interactions shape odor perception.